Engineering Cell Fate in Salivary Gland Development

Abstract
Regenerative medicine has become increasingly important in the aging U.S. society. Development of effective
regenerative therapy requires an understanding of normal cell type-specific fate determination processes—
precise mechanisms involving signals that come from interactions with neighboring cells. Currently, no reliable
salivary regenerative therapies exist due to a lack of such knowledge.
Three major types of mammalian salivary gland—sublingual, submandibular (SMG), and parotid (PG)—differ in
their physiology, acinar cell types, and disease susceptibility (1). Recent evidence suggests distinct processes
for the two types of salivary acini: mucous and serous (2). While these indicate inherent differences, salivary
cell type-specific differentiation processes have not been reported. Furthermore, while PG is most susceptible
to conditions related to dry mouth, virtually nothing is known about PG development due to difficulties with
organ isolation and culture. Thus, there is a critical need to identify cell fate determination processes specific to
salivary cell populations that comprise functional organs. In the absence of such knowledge, a mechanistic
framework necessary for the subsequent identification of therapeutic targets will likely remain difficult.
Important knowledge gaps include when and how cells commit to their fates, and whether their lineages are
plastic during development. The SMG around embryonic day (E) 13 shows epithelial morphological plasticity in
response to the adjacent mesenchyme (3), which raises a question of whether transcriptional and lineage
plasticity underlies this morphological transformation. Notably, my preliminary findings indeed show
transcriptional changes indicative of a shift in cell fate—findings I have obtained after successfully establishing
explant culture conditions to evaluate morphogenesis of SMG, PG, and recombined tissues ex vivo.
The studies proposed here were developed to elucidate salivary differentiation processes with the
ultimate goal of developing regenerative therapies targeted toward salivary gland disorders. Based
on my preliminary results and findings from other groups (3-7), my central hypothesis is that the salivary
mesenchyme guides epithelial cell fate and eventually organ specificity through interactions between
epithelial and mesenchymal tissues. The proposed program will define the regulation of the epithelium by the
mesenchyme. Further, it will provide the first comprehensive molecular characterization of cellular
differentiation processes using single cell RNA-seq of heterotypic epithelial-mesenchymal recombinants.
As a clinician scientist, my goal is to conduct research on the specific roles of epithelial-mesenchymal
interactions in lineage specificity and translate this knowledge into regenerative/therapeutic interventions. My
career development plan has been tailored toward this goal with solid mentorship and training opportunities.
In conjunction with institutional support, I am confident that studies/activities outlined in my application will
help build upon my existing skillset and facilitate my transition into an independent investigator.

Public health relevance
Project Narrative Public Health Relevance: Currently, no reliable regenerative therapies for salivary glands exist due to a lack of knowledge in cell type- specific fate determination mechanisms, which poses a substantial economic and medical burden as a result. Knowledge gained from the proposed project will provide critical information about the roles of mesenchymal cells in epithelial lineage specificity. This will aid in the development of targeted regenerative therapies to treat xerostomia (dry mouth) and disorders affecting other organs.